Cell specific roles of CD153 and CD30 in regulation of immune responses

ABSTRACT
Declining immune function in the elderly leads to increased risk and severity of infection and impaired responses
to vaccination. Our and others prior work have shown that control of immune responses in aged individuals is
complex. Although immune responses to immunization are generated in the elderly, they are tempered by
impaired intrinsic function of many immune cell types, accrual of immune suppressive and senescent cells, which
results in inappropriate localization and function of B and T cells. Strikingly however, our and other’s data also
show that age-related, decreased immune responsiveness to immunization is reversible by enhancing
stimulatory signals or reducing inhibitory signals. Thus, understanding the mechanism(s) regulating age-related
immune responses is critical to unlocking the potential for reinvigorating immune responses in aging. Recent
data from our extensive single cell genomics analysis of aged memory CD4+ T cells show that CD153 is one of
the most highly expressed genes in aged T follicular helper (Tfh) cells. Although the general consensus is that
CD153 expression on CD4+ T cells is critical for its function this remains to be rigorously tested and the cell-
specific role of CD30 remains controversial. Some data show both stimulatory and suppressive roles of CD30
on B cells; while other data shows a critical immune stimulatory role of CD30 on T cells. Thus, the cell-specific
functions of CD153 and CD30 have yet to be cleanly defined in vivo. To begin to determine the role of
CD153/CD30 signaling in regulation of immune responses in aged mice, we blocked CD153/CD30 signaling in
aged, NP-KLH immunized mice using a non-depleting, blocking antibody. Strikingly, we saw a significant
decrease in NP-specific (NP-sp.) IgG1 in the serum as well as a dramatic loss of NP-sp. GC B cells after
CD153/CD30 blockade. However, we still lack understanding of the underlying biology of CD153/CD30
interactions. Based on robust preliminary data, we hypothesize that: CD4+ T cell expression of CD153 is
sustained by IL-6 and is required to signal to CD30 expression of B cells; these interactions are critical
to promote antibody responses in aged mice. We generated mice with conditional alleles for CD153
(CD153fl/fl) and CD30 (CD30fl/fl), and will use them to (i) define the temporal role of CD153 on CD4+ T cells in
controlling antibody responses in aged mice; and (ii) define the role of CD30 and its potential for regulating B
cell responses in aged mice. Overall Impact: This research fits the R21 definition of “high-risk” as the cell-specific
roles of CD153 and CD30, may not be clear-cut. It is also ”high-reward” because, if successful, we will fill
important gaps in knowledge regarding the cell-specific and temporal roles of CD30 and CD153 in control of B
cell responses in aged mice. Further, it will enable future mechanistic studies to determine the potential for
manipulating this axis to boost B cell responses in the aged.

Public health relevance
Narrative: Declining immune function is well described in the elderly, and leads to increased risk and severity of infection, and impaired responses to vaccination. Our new data show that a cell surface molecule called CD153 interacts with another molecule called CD30 and this interaction is critical for antibody responses in aged mice. In this proposal, we will use newly generated mice that allow us to remove these molecules on specific cells at specific times to determine where and when CD153/CD30 interactions promote antibody responses in aged mice.